Immunophenotypic biomarkers to predict response and optimize immunotherapy-based combinations in breast cancer

Project Summary: Breast cancer is the most common cancer in women and responsible for over 40 000
deaths in the United States each year, therefore novel and more effective therapies are urgently needed. Initial
experience with immune checkpoint inhibition in breast cancer has demonstrated modest responses, although
durable responses have been observed. A critical barrier in developing immunotherapies in breast cancer is
the development of predictive biomarkers of response and biologically driven immunotherapy combinations.
This proposal will investigate will investigate novel translational approaches to overcoming immunotherapy-
resistance in breast cancer. In Specific Aim 1, I hypothesize that inhibition of cyclin dependent kinase (CDK)
4/6 will result in recruitment of tumor infiltrating lymphocytes (TILs) in estrogen receptor (ER) positive breast
cancer, and will result in higher responses when a programmed cell death ligand 1 (PD-L1) inhibitor is added.
This aim will focus on ER-positive breast cancer, a subtype of breast cancer that is considered “non-inflamed”
or “immunogenetically cold”, and where responses to single agent immune checkpoint inhibition has not
demonstrated significant responses. In Specific Aims 2, I hypothesize that chemotherapy with or without
immune checkpoint inhibition will upregulate hypoxia inducible factor 1 (HIF1) -alpha, and downstream
immune-evasion genes in patients with triple negative breast cancer (TNBC). While TNBC appears to have a
more “inflamed” immune phenotype than ER-positive breast cancer, responses are still modest, and predictive
biomarkers are urgently needed as well as rational drug combinations. The data generated from this proposal
will allow me to perform additional research requiring RO1 funding, including validation of biomarkers of these
pathways in larger studies, novel immunotherapy-based combinations, translational discovery of cancer-
immune cell interactions, and ultimately improve outcomes for patients with breast cancer.
Johns Hopkins houses several laboratory and clinical researchers, and provides me with an ideal
environment to conduct my research, including clinical, administrative, and research support. My background
in clinical and translational breast cancer research, including experience in collaborating with laboratory
scientists and biomarker development, poise me to successfully obtain my immediate goals including training
in the fields of cancer immunology, immunotherapeutic drug development, and bioinformatics. To this end,
under the mentorship of Dr. Elizabeth Jaffee and Vered Stearns, renowned translational investigators in cancer
immunology and breast cancer, respectively, I have assembled an advisory committee including bioinformatics
(Dr. Leslie Cope), and immunotherapy drug development (Dr. Nilo Azad). To supplement my curriculum I plan
on completing immunology courses at Johns Hopkins, and bioinformatics workshops through Cold Spring
Harbor. This career development plan will poise me to obtain the expertise necessary to eventually become a
leader in the field and bring practice changing immune-based paradigms for patients with breast cancer.

Public health relevance
Project Narrative Although significant progress has been made in developing immunotherapy, most patients, particularly those with breast cancer, do not respond; therefore, a comprehensive understanding the immune-cancer cell interactions is needed to help us identify those most likely to benefit, and guide development of immunotherapeutic strategies. In this proposal I will investigate strategies for overcoming resistance to immune checkpoint blockade in different subtypes of breast cancer via the cell cycle inhibition and hypoxia inducible factors. We will assess immune biomarker changes to determine if these can identify patients most likely to benefit from these interventions, and inform future immunotherapy-based combinations.